NCCAT: National Center for CryoEM Access and Training

Project Summary/Abstract
The National Center for CryoEM Access and Training (NCCAT), based at the New York Structural Biology Center,
provides access to state-of-the-art equipment, including specimen preparation robots, high-end microscopes
and direct detectors, screening microscopes, and all the other ancillary equipment required to solve structures
to the highest possible resolution using cryo electron microscopy (cryoEM) methods. A highly qualified technical
team provides direct support, guidance and assistance to ensure that structures of the highest quality are
produced in the shortest possible time. A cross-training program provides training to users across a wide variety
of skill levels and career goals.
We are requesting supplementing funding to support travel for invited speakers and consultants to the Common
Fund CryoEM Centers Annual Meeting that will be held May 24-25, 2022 in NYC.

Public health relevance
Project Narrative CryoEM has unique capabilities for the study of biological systems that are not accessible to other structural methods. Recent technical advances in single-particle cryoEM have made it capable of generating reliable atomic models of complete and fully functional macromolecular complexes. NCCAT provides nationwide access to state-of-the-art equipment, technical support, and cross-training to enable the production and analysis of high-resolution cryoEM structures.